Mechanisms of right ventricular dysfunction in type 2 diabetes

PROJECT SUMMARY
Heart failure in the presence of diabetes is common, expensive, and growing in significance, with some
estimates suggesting that diabetic cardiomyopathy is present in up to 60% of patients with diabetes. While
typically thought of as a disease of the left ventricle, right ventricular (RV) remodeling also occurs and
contributes to disease pathogenesis. In multiple clinical conditions, RV dysfunction is the strongest predictor of
mortality, clearly highlighting the significance of maintaining RV function. Despite the strong link between RV
function and survival, understanding of the diabetic RV is limited and thus there is a critical need to identify
mechanisms of RV-specific remodeling in the diabetic heart. In the setting of diabetes, altered myocardial
substrate metabolism causes oxidative stress, which together contribute to LV dysfunction. However, despite
strong rationale for these mechanisms in the diabetic LV, they are unstudied in the RV. The purpose of this
Katz Early Stage Investigator proposal is to identify RV-specific mechanisms of diabetic myopathy. To achieve
this goal, we propose to 1) determine the mechanism by which fatty acid uptake contributes to RV lipotoxicity
and dysfunction, and 2) identify mechanisms of impaired reactive oxygen species signaling in the diabetic RV.
Together, we will demonstrate that RV dysfunction is significant in diabetes by a mechanism involving
lipotoxicity and oxidative stress. Identifying RV-centric mechanisms of disease is critical to advance our long-
term goal of identifying treatments for the failing RV. If RV mechanisms are distinct from those in the LV, then
current therapeutic approaches will be limited in improving RV function and patient outcomes. This novel and
innovative body of work will lay the groundwork for future larger efforts aimed at understanding the
mechanisms of diabetic RV cardiomyopathy and the identification of therapies for this unmet public health
need.

Public health relevance
PROJECT NARRATIVE Heart failure in the presence of diabetes is common and deadly. While commonly thought of as occurring in the left side of the heart, right ventricular (RV) dysfunction is also present in diabetes and contributes to poor health outcomes. The purpose of this proposal is to identify the mechanisms of RV dysfunction in diabetes with the long-term goal of identifying new therapies for the failing RV.